Manufacturing Development and Commercial Readiness of an Adeno-Associated Virus-Based Gene Therapy for the Treatment of Leber Congenital Amaurosis Type 1

Project Summary/Abstract
Atsena Therapeutics is developing ATSN-101, an adeno-associated virus (AAV)-based gene therapy product,
indicated for treatment of Leber congenital amaurosis type 1 (LCA1). LCA1 is a childhood blinding disease, for
which no treatments currently exist. Atsena has compelling clinical data with ATSN-101. In a Phase 1/2 trial,
treated LCA1 patients experienced clinically meaningful improvements in retinal sensitivity and functional vision.
Atsena is now readying ATSN-101 for use in a Phase 3 clinical trial, submission for approval by the Food and
Drug Administration (FDA) and commercialization. The Direct to Phase II SBIR project aims to conduct the
manufacturing development studies necessary to yield a Phase 3 and commercial-ready ATSN-101 product.
Atsena has a clinical / commercial manufacturing platform in place, to which ATSN-101 will be adapted. The
project will 1) employ statistical approaches to define optimal process parameters and acquire adequate process
knowledge for FDA approval, 2) innovate product-specific analytical assays required for FDA approval and adopt
the industry’s best methods for analytical testing, and 3) demonstrate ATSN-101 product comparability sufficient
for FDA approval through analytical testing and a nonclinical study in a mouse model of LCA1. Atsena’s veteran
biotech team is well-equipped to execute on the project plan. The project results will enable conduct of a Phase
3 clinical trial, preparation of a Biological License Application (BLA) for ATSN-101, and ultimately,
commercialization of a gene therapy for LCA1 patients. LCA1 is rare, inherited retinal disease (IRD), readily
treatable by gene therapy. LCA1 patients have severely abnormal retinal function but maintain relatively normal
retinal structure throughout their lifetime. ATSN-101 could be an effective, vision-restoring treatment for all LCA1
patients, but will be particularly impactful for children. The consequences of extreme low vision, exacerbated in
children, include dramatically increased likelihood of neuroatypical development, quantitatively and qualitatively
reduced quality of life, and statistically increased lifelong risk of depression and mortality. This project is well-
aligned with the mission of the National Eye Institute (NEI), to eliminate vision loss and improve quality of life
through vision research. LCA1 patients have profoundly impaired vision but attained significantly improved retinal
sensitivity and functional vision after ATSN-101 treatment. If proven effective, ATSN-101 could improve quality
of life for LCA1 patients, reduce their dependence on caretakers, and reduce the overall socioeconomic impact
of IRD in the United States. This project is also well-aligned with the missions of the National Institutes of Health
(NIH) SBIR program, specifically, to increase private sector commercialization of innovations developed through
federal funding. ATSN-101 has a short path to FDA approval and commercialization. If successful, Atsena could
bring the first treatment for LCA1 to market with the help of federal funding.

Public health relevance
Project Narrative LCA1 is characterized by irreversible morbidity, in the form of severe visual impairment, and onsets exclusively in children, thus presenting a lifelong health burden. This project to develop ATSN-101 as a gene therapy treatment for LCA1 will ultimately improve quality of life for LCA1 patients, reduce the overall public health burden of IRD, and set further precedent for additional IRD gene therapy approvals in the United States.